Impact of Aspirin on the Gut Microbiome and Mucosal Microenvironment

PROJECT SUMMARY/ABSTRACT
Substantial evidence supports health benefits associated with aspirin use, particularly for individuals at
increased risk for cardiovascular disease (CVD) and colorectal cancer (CRC). In 2016, the U.S. Preventive
Services Task Force recommended low-dose (81 mg) aspirin for primary prevention of CVD and CRC despite
an incomplete understanding of the biological mechanisms underlying aspirin’s effects on the colon. We have
proposed an interrelated framework for aspirin’s biological mechanisms through direct inhibition of
prostaglandins within epithelial cells. To expand this framework, we now propose the novel hypothesis supported
by compelling preliminary data that the gut microbiome may mediate the biological effects on colorectal mucosa
associated with aspirin. The gut microbiome is a key determinant for gut homeostasis and is increasingly
implicated in the development of colorectal neoplasia. However, prospective studies are required to define the
specific role of the gut microbiome in the development of mucosa at-risk for neoplasia and how microbial
dynamics are impacted following intervention with aspirin. The overall goal of this proposal is to interrogate the
joint impact of aspirin on colonic epithelial cells and the gut microbiome in humans to refine and establish causal
mechanisms, including PG pathways, which will be further validated using novel, in vitro, patient-derived
modeling approaches. We hypothesize that by fully interrogating these additional mechanisms an integrated
network may be developed that comprehensively informs a precision prevention strategy. To address this, we
will leverage biospecimens (colonic biopsies and stool) collected within our randomized, double-blind, placebo-
controlled trial of aspirin, ASPIRED.
In Aim 1, we will deeply characterize the effects of randomized aspirin treatment on colorectal mucosa
through RNA sequencing of epithelial cells collected from mucosal biopsies and on the gut microbiome by
performing integrated whole-shotgun metagenomics, metatranscriptomics, and metabolomics to investigate the
effect of randomized aspirin treatment on the gut microbiome. In Aim 2, will leverage intestinal organoid cultures,
or three-dimensional ‘mini-guts’, to culture epithelial cells derived from the same patients with aspirin (direct
effects) and/or a priori microbial metabolites (indirect effects) to refine chemopreventive mechanisms. The results
will further elucidate a role for the gut microbiome in the health and disease states of the alimentary tract and
aligns with the overall mission of the NIDDK. This proposal will also offer a promising young investigator the
opportunity to further develop a niche within which to pursue independent lines of inquiry and expand his
bioinformatics and translational methodological skillsets. This will be an important first step for the candidate to
achieve his goal of leveraging basic science training (pre-doctoral) and experience in clinical gastroenterology
trials (post-doctoral) to become an effective bridge between the laboratory and the clinic as an independent
academic investigator.

Public health relevance
PROJECT NARRATIVE This proposal offers an unparalleled opportunity to characterize the biological impact of aspirin, perhaps the most promising widely available chemopreventive agent, and the gut microbiome on the normal colon by leveraging the uniquely valuable resources of a randomized clinical trial. To accomplish this objective, we will advance novel patient-derived modeling systems to rigorously investigate putative chemopreventive mechanisms and refine causal relationships between aspirin, the gut microbiome, and intestinal epithelial cells. Ultimately, this work may lead to novel chemoprevention targets and the development of precision prevention strategies for chronic digestive diseases.